Targeted Motor Learning to Improve Gait for Individuals with Parkinson's Disease

Abstract
The neurodegeneration in the substantia nigra of the basal ganglia that leads to Parkinson's disease (PD)
produces a progressive decline in walking function. A major barrier limiting effective walking interventions in
people with PD is the occurrence of insufficient motor learning. In the absence of disease modifying options,
dopaminergic medications and deep brain stimulation are often used as the disease progresses. Although
effective at improving gait, these solutions are temporary, concealing the concurrent degeneration of
dopaminergic neurons. As a result, these solutions become less effective at improving gait as the disease
progresses and can wear off later in the day. Physical therapy has the potential to increase walking capacity as
well as create long-term improvements through intensive training that focuses on motor learning. In particular,
the use of rhythmic auditory cues is a well-established intervention that attempts to overcome the damage to
internal cueing mechanisms. Despite consistent benefits observed immediately after training, the long-term
(retention) effects are more mixed. We contend that reduced retention is a result of inadequate motor learning.
Conventional rhythmic auditory cueing employs strategic (explicit) learning with use-dependent learning. To add
implicit learning mechanisms to rhythmic auditory cueing, a subtle error in the tempo can be introduced that
requires recalibration (i.e., error-based learning). We propose that the addition of frequent movement
recalibrations via subconscious temporal distortions of rhythmic auditory cues will repeatedly engage the early
phase of implicit learning for individuals with PD to involve intact neural pathways (i.e., hippocampal driven
encoding) for improved motor learning and longer term retention of gait improvements. As this training has the
potential to alter neural circuitry, we will assess the neural substrates induced by this intervention through
multimodal markers of hippocampal and striatal structure and connectivity. Specifically, we will use a randomized
controlled design to perform four weeks of gait training using either no metronome, a metronome with a fixed
tempo (strategic learning), or a metronome with a slowly changing tempo (strategic learning + error-based
learning). In Aim 1, we will assess the gait behavioral changes post-training and at a 3-month follow-up to
determine retention. In Aim 2, we will explore structural and functional neural changes induced by the gait training
interventions. Our team is exceptionally well prepared to perform these Aims, consisting of experts in gait
neurorehabilitation and biomechanics (Lewek), motor learning and neuroimaging (Dayan), and Parkinson's
disease clinical care (Browner). At the conclusion of this project, we will have determined the available
mechanisms of motor learning for people with PD, and will have examined the neural substrates that can be
targeted to maximize remaining intact neural circuitry. This project has the potential to alter the manner in which
rehabilitation is performed with people with PD, using a disease specific motor learning paradigm that makes
use of residual neural circuits for long-term retention of functional motor skills.

Public health relevance
Project Narrative People with Parkinson's disease exhibit reduced walking ability that can be addressed by physical therapy. Learning how to improve walking represents a considerable challenge for patients and rehabilitation professionals. The proposed project will determine how to improve motor learning related to walking, through residual intact neural pathways for improved gait and long-term retention of functional benefits.